Drinking water arsenic and uranium: associations with urinary biomarkers and diabetes across the United States

PROJECT SUMMARY/ABSTRACT
In the United States (US), diabetes mellitus affects an estimated 34.2 million people, representing 10.5% of the
population, with 90-95% of diabetes cases characterized as type 2 diabetes mellitus (T2DM). Diabetes
prevalence has increased over time, with disparities by race/ethnicity. A review endorsed by the American
Diabetes Association recently identified exposure from toxic metals/metalloids, such as arsenic (As), as a risk
factor for T2DM. Less is known regarding the role of uranium (U). Drinking water represents a major source of
inorganic As and U exposure in the US, for both users of unregulated private wells and of regulated public
water. A current gap in knowledge is the contribution of drinking water to total As and U exposure, as
determined in urine, in general US populations, and whether drinking water As and U exposures are
associated with T2DM risk nationwide. Our objective is to examine the association of drinking water As and U
exposures with a) urinary metal/metalloid concentrations, and b) T2DM incidence and prevalence. Evaluating
drinking water metals/metalloids and T2DM can directly inform drinking water regulations that currently do not
consider T2DM as a health endpoint. Nationwide, analyses in diverse epidemiological populations are needed
to assess T2DM susceptibility across race/ethnicity and socioeconomic status groups, critical to understanding
and reducing health disparities. It is also important to assess whether the current public water Maximum
Contaminant Levels (MCLs) for As and U are adequately health protective. The association between water As
and U with their corresponding concentrations in urine in US populations has historically been difficult to
examine due to a lack of water composition data that could be linked to epidemiologic cohorts. Recently,
however, robust estimates of public water As and U and private well As data have been developed nationwide.
We will study three diverse epidemiologic cohorts in the US: the Multi-Ethnic Study of Atherosclerosis (MESA),
a prospective study of cardiovascular disease among diverse urban communities (incidence and prevalence);
the Strong Heart Family Study (SHS), a prospective study of cardiovascular disease among American Indian
communities (incidence and prevalence); and the National Health and Nutrition Examination Survey
(NHANES), a series of cross-sectional surveys representative of the general US population (prevalence). We
will evaluate the association of water As and U with T2DM risk by sex, race/ethnicity, age, SES, and by levels
of the other metal. We hypothesize that the contribution of drinking water to urinary metal/metalloid
concentrations will decrease following the implementation of the As and U MCL change. This study will
highlight subpopulations at increased susceptibility of water As and U-associated T2DM, will identify regions
and communities where future interventions to reduce drinking water As exposures are needed, and will inform
future regulatory needs including T2DM as a potential health endpoint for drinking water As and U.

Public health relevance
PROJECT NARRATIVE The proposed study will use nationally representative databases, including data from two longitudinal cohorts of multi-ethnic urban US, and American Indian populations to explore temporal, geographic, and sociodemographic trends in water arsenic (As) and uranium (U) exposure and disease. Our study will evaluate the contribution of drinking water As and U to total As and U exposure, as determined in urine in general US populations, and whether water As and U exposures are associated with diabetes risk nationwide. There is a critical need to identify whether the current Maximum Contaminant Levels for As and U are adequately effective in reducing exposure and protective of health outcomes not considered in existing federal regulations, such as diabetes, nationwide and in different race/ethnicity and socioeconomic groups.